Neurocognitive Aging, Health Disparities Research and Education

Abstract. The stark disparities in Alzheimer’s Disease and Related Dementia (ADRD) incidence and outcomes
across racial and ethnic groups are urgent issues necessitating further research. We also need further
investigation in identifying and deciphering both modifiable risk factors, including obesity, physical activity,
socioeconomic environments, as well as genetics and/or the combined effect of gene-environment interactions
associated with neurocognitive aging deficits in diverse populations. The availability of open-access data
allows us the opportunity to more readily address multiple variables and factors associated with neurocognitive
aging across various ethnic/racial groups. Therefore, this supplement aims to examine ADRD health
disparities within and between racial/ethnic groups via leveraging large open-access datasets, as well as
develop corresponding curricula workshops. (1). Research Aims: To examine the association between
modifiable risk factors, ADRD markers (genetic, protein and imaging), gene-by-environment interactions, and
co-morbid conditions with neurocognitive aging and ADRD outcomes across racial/ethnic groups in three large
open-access data: the National Alzheimer’s Coordinating Center (NACC), the Global Alzheimer’s Association
Interactive Network (GAAIN) and All of Us. 1a. To investigate, via the NACC dataset, the relationship between
co-morbid conditions, such as diabetes, hypertension, hormone-related cancers with mild cognitive impairment
(MCI) and dementia (specifically AD) within and between NHW, Hispanic and Black groups. Hypothesis: Co-
morbid conditions are associated with MCI and AD dementia, and that the relationship varies between
racial/ethnic groups. 1b. To investigate, via GAAIN, the association between obesity and APOE4, ADRD
markers (beta-amyloid (Aß), tau and brain structure) and respective epigenetic risk factors with ADRD
outcomes across the Hispanic diaspora. Hypothesis: Obesity and APOE4, ADRD markers [beta-amyloid (Aß),
tau and brain structure] are associated with ADRD, and varies across the Hispanic diaspora globally. 1c. To
explore, via All of Us, the association between obesity, physical activity and socioeconomic risk factors with
dementia and dementia across NHW, Hispanics and Blacks. Hypothesis: Obesity, physical activity and
socioeconomic risk factors are associated with dementia and will vary by race/ethnicity. Where feasible, all
hypotheses will be tested and compared across all three datasets. In addition, we will apply both traditional
and modern machine learning techniques to these datasets. (2). Training Aim: To develop curricula for
utilization, access, data content, and exploratory analyses of the three open-access datasets/platforms. The
curricula will be offered and evaluated via workshops for diverse CSUF students (n = 10 per three workshop
series). Diversity, Equity, Inclusion and Accessibility (DEIA) program and mentorship components will be
evaluated as well.

Public health relevance
PROJECT NARRATIVE Brain-related aging and health, including Alzheimer’s disease and related dementia (ADRD), have enormous impact on families, individuals and our society. Also, research shows that there are stark racial/ethnic differences in brain-related health, and therefore the need to decipher socioeconomic, lifestyle, co-morbid conditions and biological factors contributing to these disparities is urgent. Research and research education tackling modifiable risk, treatable co-morbidities and genetic influences across racial/ethnic groups will provide new avenues to address and bolster neurocognitive aging health equity, and therefore should be prioritized.